GYNECOLOGIC ONCOLOGY FELLOWSHIP PROGRAM

Continuing support is requested for the University of California, Irvine's Gynecologic Oncology Fellowship program. This fellowship program, administered by UCI's NCI-designated Chao Family Comprehensive Cancer Center, is entering its 19th year. The Gynecologic Oncology Fellowship program is geared toward training physician scientists in the sub-specialty of gynecologic oncology by providing multiple levels of interaction between basic and clinical scientists to facilitate the transfer and exchange of information. The fellowship program provides trainees with opportunities for the practice application of skills in the design and testing of scientific hypotheses. Trainees receive three years of research training, consisting of two years training in the basic sciences followed by one year of clinical/translational research training. There are 31 training faculty, made up of 21 basic scientists and 10 clinical researchers from 10 departments in the School of Biological Sciences and College of Medicine. Faculty mentors have research concentrations in the following areas: photomedicine, structural molecular biology, growth factors and signaling, cell transformation and carcinogenesis, cancer epidemiology and cancer genetics, cancer screening and prevention, and experimental therapeutics. Twenty-seven of the training faculty have active, peer- received, research grants. Support is requested for 5 postdoctoral fellowship positions. Competition is keen for the one to two available fellowship positions annually. Recruitment for the fellowship program draws from the 1,200 Obstetrics and Gynecology residency positions nationwide. Over 90% of the graduated fellows from the program have gone on to academic faculty positions. Training features of the program included didactic coursework in the areas of responsible conduct of research, biostatistics and epidemiology, and cancer-related elective, national scientific meetings, and numerous other multi-disciplinary seminars, lectures and symposia.